Selective galactosylceramidase ablation to study the pathogenesis of Krabbe leukodystrophy

Krabbe disease (KD), or globoid cell leukodystrophy, is the most fatal form of the demyelinating
neurodegenerative lysosomal storage disorders. KD is caused by mutations in the gene for
galactosylceramidase (GALC), which results in toxic accumulation of its enzyme targets, psychosine and
galactosylceramide. Most cases involve the infantile-onset form, which is typically fatal by 2 years of age.
Hematopoietic stem cell transplantation is the only treatment available and partially attenuates the course of KD
when delivered before symptoms appear. This highlights our lack of understanding of the basic mechanisms at
play and the pathogenic cascade of KD. It is therefore essential to decode cellular responses to the loss of GALC
and understand the interplay between the brain cell types driving the demyelination and neurodegeneration. We
used a novel conditional Galc knockout (CKO) mouse model in an unbiased approach to evaluate the loss of
Galc function in different cell types in the mouse brain in vivo. We found that oligodendrocyte (OL)-specific Galc
CKO mice have a KD-like phenotype. Notably, GALC-deficient OLs die by an iron-dependent form of
programmed cell death known as ferroptosis. We also conducted Translating Ribosome Affinity Purification
(TRAP)-Seq analysis of brain tissue from mice with OL-specific Galc CKO, which revealed a dramatic
upregulation of the gene encoding secretory protein lipocalin-2 (LCN2), a target of the proinflammatory
transcription factor NF-kB that induces neuroinflammation. Our conditional mouse models also revealed that
Galc ablation from both OLs and microglia results in a much more severe KD phenotype. However, the
exacerbation occurred in the absence of any additional accumulation of psychosine, indicating an unknown
contribution from microglia. Further studies revealed that under conditions of GALC deficiency, microglia
upregulate their expression of osteopontin (OPN), a secreted phosphoprotein that recruits additional immune
cells and promotes microglial engulfment of debris and damaged cells. Building upon these discoveries, we
hypothesize that GALC deficiency in OLs triggers activation of the NF-kB pathway and inflammatory and
ferroptotic processes in OLs, which involve the upregulation of LCN2. In addition, GALC-deficient microglia
secrete OPN and attract more immune cells to exacerbate neuroinflammation in KD. We propose studies to
determine the mechanisms by which (i) GALC-deficient OLs, (ii) GALC-deficient microglia, and (iii) NF-kB activity
contribute to KD pathogenesis. By combining a series of in vitro and in vivo experiments, we will study specific
molecular mechanisms in which GALC deficiency triggers cell autonomous dysfunctions that progress to
manifest as KD. We will decode the cellular interplay between OLs and microglia in the brain that drive the
demyelination and neuroinflammation characteristic of this and other neuroinflammatory diseases. These studies
will reveal novel pathogenic mechanisms that could translate to important targets for therapeutic interventions.

Public health relevance
Krabbe disease (KD) is a progressive and fatal neurologic lysosomal storage disorder that usually affects infants and causes death before 2–3 years of age. The only available treatment, hematopoietic stem cell therapy, is not sufficient to improve the long-term survival of most patients with KD. Using our newly developed preclinical KD models, we will evaluate the mechanisms by which the critical brain cell types and molecules contribute to the disease in an effort to identify novel targets for new therapies.